A multi-modal approach for efficient, point-of-care screening of hypertrophic cardiomyopathy

NOT APPLICABLE - Please refer to original proposal.

Public health relevance
NOT APPLICABLE - Please refer to original proposal.